High dimensional motor coding and motor dysfunction in Rett syndrome

Project Summary/Abstract
The broad, long-term goals of the proposed research are to better understand the neural
underpinnings of healthy motor function and motor dysfunction in Rett syndrome and to promote
undergraduate involvement in health-related research. Rett syndrome (RTT) is a neurological
disorder, caused by disrupted function of the gene MeCP2, typically resulting in severe cognitive
and motor disability. What goes wrong in the motor signals sent from the brain to the body,
leading to motor dysfunction in RTT, remains largely unknown. Based on our recent work in
rodent models, together with the fact that seizures are prevalent in RTT, here we hypothesize
that excessive synchrony among neurons in the motor system may disrupt motor coding by
limiting the dimensionality of motor signals. The essential idea here is that extreme synchrony
entails many neurons doing the same thing, which precludes the complexity of signals required
for controlling complex body movements. A complete and quantitative understanding of this
idea is best approached using the framework of high-dimensional geometry. In this framework,
excessive synchrony causes a collapse of the motor coding subspace, which is likely to
entangle signals and collapse the complexity of body movements. The proposed work has
three promising potential outcomes. First, we leverage state-of-the-art ideas from high-
dimensional geometry of population motor coding to advance RTT etiology. Second, we
provide an important counter-example of what can go wrong when high-dimensional geometry
is disrupted, thus advancing basic knowledge of motor systems neuroscience. Third, we will
test new RTT treatment strategies with potential for future translation from lab to clinic. Our first
specific aim is to determine how MeCP2 dysfunction alters population coding in motor cortex
and striatum. We hypothesize that excessive synchrony will result in reduced dimensionality of
the population motor code, which manifests as motor dysfunction. Our second specific aim is to
test two promising treatment strategies, one pharmacological, and one based on physical
therapy. We hypothesize that these treatments will partially recover wild-type dimensionality of
motor coding. To test these hypotheses, the proposed research would use high-density multi-
electrode measurements to monitor the spiking activity of many single neurons in motor cortex
and striatum of head-fixed mice as the animal runs on a computer controlled wheel. The
research will be performed by a team of three undergraduate students and one postdoc. The
proposed work would build upon the success of another recent R15 grant which resulted in a
PNAS publication including an undergraduate author.

Public health relevance
Project Narrative The signals sent from our brain to control our muscles require intricate interactions among large populations neurons in motor cortex and striatum. Recent advances in understanding population motor coding indicate the importance of high-dimensional geometric neural representations of body movement, but how these newly discovered motor coding mechanisms go wrong in brain disorders with motor dysfunction is unknown. The research proposed here would engage undergraduate researchers and reveal how high dimensional geometry of motor coding is disrupted in a transgenic animal model of Rett syndrome, a severe neurological disorder with prominent motor dysfunction.